Informatics Research

Our overall mission is to derive actionable insights from integrating translational research data and to accelerate translation of findings into the clinic. Our efforts span the following general areas: 1) translational data analytics: development of custom workflows to interpret complex datasets such as multi-omic and clinical data, and application of data science approaches to predict translational research outcomes as well as development, maintenance, and deployment of workflows, web and mobile apps to disseminate our robust methods and data; 2) standards, knowledge sources, and software: connecting and supporting analyses of various types of experimental and curated datasets; in-house curation efforts; 3) project management, communications, and outreach: enabling the team to collaborate and deliver robust solutions and tools as well as conducting training and hands-on support. These general areas are highly synergistic, where work one area informs work in other areas.